Curve-free phase I/II clinical trial designs for molecularly targeted agents and immunotherapy

Project Summary/Abstract
The primary goal of this proposal is to develop transparent, ﬂexible and efﬁcient phase I/II clinical trial designs
identifying optimal doses for molecularly targeted agents (MTA) and immunotherapy (IT). Conventional phase I/II
clinical trial designs often use sophisticated parametric models to characterize the joint toxicity-efﬁcacy distribu-
tions and to conduct the trials. However, the parametric models are hard to justify in practice, and misspeciﬁcation
of parametric models can lead to substantially undesirable performances of phase I/II trials. Moreover, it is difﬁcult
for the physicians conducting the trials to clinically interpret the parameters of these sophisticated models, and
such great learning costs impede the translation of novel statistical designs into real-world trial implementation.
To solve these issues, in this proposal we will propose transparent curve-free phase I/II clinical trial designs.
The proposed designs make no parametric assumptions on either dose-response relationship or toxicity-efﬁcacy
correlation and therefore performs robustly under any clinically meaningful dose-response curves. The concise
clinically interpretable model expression and dose-ﬁnding algorithm make the proposed designs highly transla-
tional from the statistical community to the clinical community. The proposed designs are also highly ﬂexible
because they are applicable for both single-agent trial and drug-combination trial with either quickly observable
outcomes or delayed outcomes. The preliminary simulation studies show that the proposed designs are highly
efﬁcient in optimal dose selection and patient allocation. In addition, we will develop user-friendly web apps to
facilitate the widespread application of the proposed designs in clinical practice.

Public health relevance
Project Narrative Molecularly targeted agents (MTA) and immunotherapy (IT) represent the most promising cancer treatments in recent decades. The proposed research aims to provide transparent, ﬂexible and efﬁcient Bayesian adaptive phase I/II clinical trial designs which can be easily used by physicians to identify optimal doses of MTA/IT yielding most desirable therapeutic effects.